Peptidoglycan Fragment Library to Investigate Innate Immune Responses

PROJECT SUMMARY
Bacterial cells surround themselves with a peptidoglycan (PG) cell wall, an essential structure that provides cell
shape, and resists changes in osmotic pressure and other environmental insults. In addition, PG is highly
inflammatory and an important trigger of innate immune responses across the animal kingdom. However, study
of these important PG fragments has been hampered by the lack of reproducible, chemically defined, and high
quality reagents. We hypothesize that the natural diversity of the generated PG fragments poses unique
challenges to the innate immune system that utilizes specific uptake, transport, and receptor systems for sensing
and responding to the presence of the bacterial cell wall derived molecules. The goal of this proposal is to
develop a biologically relevant PG fragment library and PG synthesis strategies to facilitate a more
precise understanding of PG mediated immune responses in the context of health (homeostasis) and
inflammatory diseases. In the initial funding period, we used our PG library and genome wide transcriptome
analysis to uncover that distinct PG fragments indeed induce specific immune responses, through related but
distinct PG sensing receptors. We were successful in our aims to produce a fragment library, print a PG array,
share the fragment library with multiple laboratories and to discover that specific immune receptors recognize
discrete peptidoglycan fragments. Transporters responsible for the cellular internalization of specific PG
fragments were defined and novel innate immune sensing complexes were identified. The project has now
developed into a mechanistic phase with a keen focus on intestinal innate immunity and inflammation, where
our team of chemical biologists and immunologists will work together to innovate PG production strategies and
fine tune PG probes to better understand the specificity of their trafficking and signaling modalities. Ultimately,
we aim to learn the molecular requirements for cellular uptake and innate immune recognition of a variety of PG
fragments, especially in mucosal macrophages, by the characterizing the SLC transporters involved and the key
innate immune receptors - PGLYRPs and the NOD proteins required. This renewal aims to enhance the PG
library with additional modalities for partner capture (both in cellular, animal models and array format), synthesize
and screen for inhibitors for bacterial cell wall uptake and recognition, and define the pathways driving specific
gene expression outputs, all building upon the results from the previous funding cycle: Aim 1: Identification and
fermentation of biologically relevant PG fragments, Aim 2: Defining requirements and mechanisms for PG
fragments entering macrophages Aim 3. Define the role(s) of mammalian Peptidoglycan Recognition Proteins
(PGLYRPs) in innate immunity and mucosal protection. Ultimately, this dynamic team will set the stage for the
future development of small molecule modulators, PG based immunotherapies, adjuvants, and
biomarkers while at the same time, sharing new tools with the microbial and immunological communities.

Public health relevance
PROJECT NARRATIVE Understanding the interaction between the bacterial cell wall and our immune system is critical to advancing human health. This interaction is an important pathway contributing to both chronic inflammatory diseases and host defense against microbial infections. We will develop physiologically relevant but chemically-defined cell wall fragments to probe the immunological properties of bacteria. This information will be critical for dissecting the communication between the microbiome and the GI tract and the skin, and in designing novel antibiotics and effective treatments for inflammatory disorders.